Mechanism of Selenoprotein Synthesis

RELEVANCE Studies in human subjects and animal models indicate gender-specific differences in Se utilization and metabolism. Selenium supplementation at high levels in a clinical study resulted in increased risk for development of type 2 diabetes in men but not in women, and our results indicate gender-specific differences in Se handling in animals. These findings have crucial implications for the use of Se supplements in human health and disease, and highlight the importance of investigating the mechanistic basis for these gender- specific differences.

Public health relevance
PROJECT NARRATIVE Studies in animals and humans indicate gender-specific differences in Se utilization and metabolism, resulting in differential susceptibility to numerous diseases. We are investigating the mechanistic basis for gender- specific differences in development of neurological deficits, metabolic disorders and male infertility in mouse models in which Se metabolism and transport are disrupted.